A new class of biosensors for detecting signaling dynamics without live-cell microscopy

PROJECT SUMMARY
Every cell exists in a complex and changing environment. To deal with their complex surroundings, cells
have evolved diverse systems to sense external cues (such as nutrients, stresses, or communication
molecules from neighboring cells) and store this information in an internal representation. Yet the details of this
internal representation are still mysterious. What patterns of protein activity do cells use to represent
information about their environment? How are these patterns generated, and what fates do they control?
Growth factor signaling is an important model system for understanding principles of cell signaling, where
activation of cell surface receptors is coupled to activation of a membrane-localized protein Ras, the kinase Erk
and various downstream genes. Growth factor signaling plays crucial roles in embryo development (where
growth factors trigger cells to differentiate), adult tissue regeneration (where it controls various aspects of
wound healing), and cancer (where mutations in growth factor signaling genes drive uncontrolled growth and
tumorigenesis). Owing to its importance, growth factor signaling is intensely studied at increasingly high
resolution. Biosensors are now available to monitor Erk activity in real-time and in living cells, enabling the
experimentalist to trace fluctuations in growth factor signaling from one cell to another across a tissue and in
different cellular contexts.
Studies using Erk biosensors have revealed previously-unappreciated complexity in growth factor signaling
activity. Instead of simply turning from off to on upon stimulation, Erk may pulse on and off rapidly in cells, or
even exhibit traveling waves of activity that propagate across entire swaths of tissue. Yet the field does not yet
understand whether Erk pulses lead cells to adopt distinct functional states, nor how the pulses themselves are
generated by biochemical networks inside or between cells. This state of affairs is not unique to Erk: pulses
have also been widely observed in many other signaling pathways and are generally poorly understood.
The current proposal aims to provide new tools for studying signaling pulses to aid their study in cultured
cells and in living animals. We have invented a new technology – a prototype gene circuit that acts as an Erk
“pulse detector” – which will allow researchers to study Erk pulses without live imaging. This technology
addresses an important need: currently, pulses can only be detected by high resolution microscopy of living
cells, limiting contexts where they can be studied. Here, we propose to develop our imaging-free biosensor for
rapid deployment in mouse and human cell lines, to expand its design to other pathways and signaling
dynamics, and to establish transgenic animals expressing the biosensor for studies in many tissues where
microscopy is difficult or impossible to perform. Successful completion of this work will produce a new class of
biosensors to shed light on complex signaling with potential impact on human disease.

Public health relevance
PROJECT NARRATIVE Cell signaling proteins such as the Erk kinase play a crucial role in embryo development, cancer, and the developmental defects known as RASopathies. A major hypothesis in the field is that cell adopt different fates depending on whether Erk is activated in a short pulse or a long plateau, but studying these dynamics remains extremely difficult. We propose to develop a new class of biosensors for detecting signaling pulses from Erk and other pathways, opening the door to a better understanding of their role in development and disease.